Oregon BIRCWH: Scholars in Women's Health Research Across the Lifespan

This application is for competing renewal of the “Oregon BIRCWH: Scholars in Women’s Health
Research Across the Lifespan” program. The overarching goal of our program is to recruit earlystage research faculty from different backgrounds and disciplines and develop them into scientific
leaders who advance interdisciplinary research in women's health and sex differences research
across the lifespan. The Oregon BIRCWH has successfully trained 36 scholars who have
received over $268 million in research funding, published over 1,440 peer-reviewed papers, and
received endowed chairs and leadership roles in academics, industry and federal agencies. The
unifying theme of our program centers on the lifespan. Scientifically, Oregon BIRCWH Scholars
and mentors lead innovative, cutting-edge research across the entire lifespan from in utero and
childhood to reproductive age and late adulthood. Professionally, we recognize that networks and
mentoring are critical supports for BIRCWH Scholars throughout their careers. Scholars are
selected through a highly competitive process. The Oregon BIRCWH provides: 1) a robust
mentored research and training infrastructure that promotes interdisciplinary women’s health and
sex differences research; 2) a welcoming, strong and enduring culture of collaboration and
mentorship that promotes team science; and 3) a proven process to recruit, train, and support
faculty from different backgrounds and disciplines who become national research leaders and
expand the footprint of women’s health and sex differences research. The Oregon BIRCWH
prioritizes the goal of professional development, leverages our distinguished programs and
unique position as an institution-wide K12 career development program specifically dedicated to
women’s health and sex differences research to advance the NIH ORWH strategic plan for
women’s health research at institutional, regional, and national levels. Innovative expansions
proposed in this renewal include: 1) enhancing our campus-wide approach to recruitment and
expansion of the BIRCWH infrastructure to attract, support, and nurture scholars of different
backgrounds and disciplines; 2) drawing upon the program’s legacy and success to introduce a
core curriculum specifically tailored to BIRCWH Scholars, called “BIRCWH Essentials by
BIRCWH Alumni”; 3) leading inter-institutional conferences and events to promote innovative
thinking, networking, and collaboration; and 4) developing “BIRCWH Connect”, a social media
platform to support an actively engaged BIRCWH community across the country. The broad
institutional support, interdisciplinary environment and committed leadership position the Oregon
BIRCWH to drive the future of women’s health and sex differences research for years to come.

Public health relevance
Project Narrative The diverse across overarching goa l of this training program is to foster the development of early-stage research faculty from backgrounds and disciplines to develop leaders in women's health and sex/gender-based research the lifespan. We apply the lifespan approach to faculty career development and science preparing BIRCWH Scholars to lead new initiatives advancing NIH ORWH research priorities.